Deviant Synchronization of Neural Functions in Schizophrenia

Perceptual distortions in the form of hallucinations and illusions are defining characteristics of psychotic
psychopathology. Recent evidence suggests that the formation of percepts is directly influenced by cycling
neural activity (i.e., oscillations) captured in brain wave recordings and reflective of processes by which brain
circuits encode stimuli. The pace of the resting state alpha cycle (~8-12 Hz) appears to govern the speed at
which visual input is sampled with faster alpha oscillations yielding more accurate visual perception. But it is
unknown whether abnormal oscillations evident during the brain’s default mode can account for the distorted
perceptions that characterize psychosis. The current project is an investigation of the role of default mode
oscillations in perceptual dysfunction in schizophrenia, and tests whether altering oscillations can improve
visual perception. The overarching hypothesis is that schizophrenia is associated with slowed alpha
oscillations that contribute to visual perceptual dysfunction evident during experimental tasks and real-world
situations where illusions and hallucinations occur.
To investigate alpha oscillations as a possible mechanism of reality distortion in psychosis the proposed
work involves the following aims. First, electroencephalography (EEG) will be used to measure individual alpha
peak frequency (IAPF) in people with schizophrenia and healthy controls to determine how the speed of default
mode resting state oscillations is relevant to visual perceptual functions commonly disturbed in schizophrenia.
Data from a binocular rivalry task that samples endogenous processes of percept formation will be used to test
the hypothesis that individual alpha peak frequency (IAPF) reflects the rate of sampling of visual information
and determines the pace of percept formation. It is expected that slowed alpha oscillations in schizophrenia
reflect impaired neural functions that underly percept formation and limit the ability to discern visual stimuli. It is
also predicted that slowed alpha oscillations in schizophrenia are related to cognitive impairment, clinical
symptomatology, and real-world visual distortions in the disorder. Functional magnetic imaging (fMRI) data will
be simultaneously collected with EEG to isolate regions of the thalamus and occipital cortex that are
associated with alpha oscillations. fMRI will be used to test the hypothesis that slowed alpha reflects reduced
thalamic-cortical connectivity in schizophrenia.
Second, advanced time-frequency (TF) analysis techniques of EEG will be used to examine how default
mode oscillations relate to the synchronization of neural responses during the processing of visual stimuli. This
will help reveal how IAPF influences visual perceptual disturbances in schizophrenia. In addition to showing
that decreased speed of alpha oscillations is associated with decreased synchronization of oscillations to
briefly displayed visual stimuli (i.e., DS-CPT), it is expected that decreased synchronization of oscillations will
predict worse perceptual function, clinical symptomatology, and real-world visual distortions in schizophrenia.
We will use simultaneously acquired fMRI data to examine whether decreased alpha synchronization during
visual processing is associated with reduced modulation of connectivity between thalamus and occipital cortex
in schizophrenia.
Third, we will modulate alpha oscillations to causally influence visual perception. A flickering visual display
will be used to entrain neural oscillations and briefly alter IAPF during visual perceptual tasks. The
manipulation of IAPF will specifically test whether modulation of the speed of the alpha rhythm yields improved
visual perceptual function in people with schizophrenia. Entrainment of oscillations 2 Hz above IAPF as
compared to 2 Hz below IAPF is expected to increase the speed of percept formation as measured during
binocular rivalry and improve visual perceptual performance as measured by the DS-CPT.
The proposed work will inform future implementation of neuromodulatory interventions in Veterans.

Public health relevance
In previous years the total cost of care for Veterans with psychoses has consumed 16% of the Veterans Health Administration (VHA) Veterans Equitable Resource Allocation (VERA) funds. The current investigation is intended to reveal the importance of brain waves – or oscillations - to abnormal visual perceptual experiences and symptoms of psychosis such as hallucinations and illusions. The value of the work is that oscillatory abnormalities can serve as targets for brain interventions that reduce perceptual dysfunction and psychotic symptomatology. Through state-of-the-art analysis of brain electrical activity in people with schizophrenia, this study will test whether the speed of a dominant brain oscillation (i.e., the alpha rhythm) accounts for difficulties in adapting to visual input and accurately seeing objects in one’s environment. The work includes a manipulation of the rhythm to determine if perception can be improved. Alpha manipulation will be personalized and inform neuromodulatory treatment focused on the speed of a Veteran’s alpha rhythm.